Effects of asymmetries on binaural-hearing abilities across the lifespan

ABSTRACT: Binaural hearing allows people to benefit from perceiving sounds from different spatial locations
and is critical in solving the “cocktail party problem” (i.e., understanding speech in the presence of competing
background sounds and noise). A vast majority of human binaural-hearing data have been collected in partici-
pants with highly symmetric hearing thresholds (≤10 dB threshold differences across the ears). Those with hear-
ing asymmetries will include many of the 80 million “Baby Boomers” in the US who are reaching the important
milestone of older age (>65 yrs). As we get older, hearing loss increases, binaural abilities decrease, and the
cocktail party problem becomes increasingly difficult. We know very little about how binaural hearing is impacted
by hearing asymmetries and how it changes across the lifespan. The long-term goal of this research is to deter-
mine the mechanisms underlying how age and hearing loss impact speech-perception in noise and cocktail-
party situations. The objective of this proposed project is to understand how age-related binaural-hearing deficits
are affected by small to large hearing asymmetries. To achieve this objective, we will undertake two specific
aims: 1) generate an audiological and binaural-hearing dataset for a large cohort of participants that vary in
hearing asymmetry, age, and hearing loss; and 2) use machine learning to generate innovative and unexpected
hypotheses relating audiometric variables and basic binaural-hearing abilities to the cocktail-party problem. The
need is great because the typical approach usually provides modest (and expected) increments of knowledge.
Using of machine learning has the power to uncover complex associations in large data sets to generate inno-
vative and unexpected hypotheses, but has not yet been applied to understanding aging, hearing loss, and
binaural hearing. This knowledge will help us better understand how hearing asymmetries affect communication
in cocktail-party situations as individuals age and lose their hearing. This contribution of this research is signifi-
cant because it will lead to improvements and breakthroughs in audiological care and hearing interventions,
which will only be possible once we better understand how the cocktail party problem and spatial-hearing abilities
change with age, hearing loss, and hearing asymmetry.

Public health relevance
The proposed research is relevant to public health because millions of older adults living in the United States experience decreased quality of life because of difficulty communicating, particularly in the common situation when there is background noise. This research aims to understand how age and hearing loss impacts spatial hearing, one major way the brain minimizes the effects of background noise on speech perception. Thus, the proposed research is relevant to the NIH mission to develop new knowledge and improve technologies to help treat disability and the NIDCD mission to provide technological interventions for hearing loss.